SyncroPatch 384 Automated Patch Clamp Instrument

The objective of this proposal is to enhance the capability of a diverse group of researchers funded by
National Institute of Mental Health in the greater Boston area to perform electrophysiological assays for
the purposes of drug discovery, targeted pharmacological studies, determining the functional
consequences of human ion channel variants associated with genetic diseases, and investigating the
electrophysiological properties of human neurons. This objective will be achieved by the purchase and
installation of a 384-well automated planar patch clamp instrument (SyncroPatch 384) manufactured by
Nanion Technologies. This instrument will replace the 7-year-old legacy instrument (SyncroPatch 384
PE) this is approaching obsolescence and lacks critically important features that are needed by
researchers. The Nanion SyncroPatch 384 instrument consists of a patch clamp module (measurement
chamber) integrated with a state-of-the-art robotic liquid handler with a 384-pipetting head (Biomek i5),
384 individual patch clamp amplifiers that can operate in either voltage-clamp or current-clamp mode,
advanced temperature control with range 10°C to 37°C, and powerful user-friendly software for
instrument control and data analysis that runs under a supported operating system. The instrument
allows for formation of giga-Ohm resistance seals with a variety of cell types and produces
electrophysiological recordings with high fidelity that are comparable to the traditional manual patch
clamp technique but at two orders of magnitude greater throughput. The instrument will be managed by
the ICE-T (ion channel and electrogenic transporter) platform at Broad Institute. Strong institutional
support for the instrument and its deployment will be provided, and effective oversight will be achieved by
a team of professional scientist. The instrument is expected to enhance the success of several NIMH -
funded research projects and provide a new platform for active and future research.

Public health relevance
This proposal seeks funding to purchase an automated patch clamp instrument (SyncroPatch 384, Nanion Technologies) that can perform a wide range of electrophysiological recordings on various cellular models in 384-well high throughput format. The instrument will be used by a diverse group of researchers funded by NIMH who are developing incisive chemical tools for ion channels, studying the regulation of neuroreceptors, investigating the functional consequences of human ion channel mutations, and studying the electrophysiological properties of human neurons. The instrument offers specific features that will enhance the success of these NIMH-funded research projects.